COMPUTER ASSISTED SMOKING CESSATION DEVICE

The problem of smoking and the difficulty of cessation are well documented phenomena. Despite large numbers of successful quitters, approximately 54 million adults continue to smoke. Surprisingly, a majority of these individuals report that they would like to quit smoking. One approach that may hold promise for these smokers is to apply computer technology in a self-help format to individualize the treatment of smoking. The capacity of computers to individualize a cessation program based on research on nicotine addiction could provide an important break through in smoking cessation. Heretofore, individualization of self-help programs was virtually impossible. Likewise, even therapist led programs based on a nicotine addiction model have not individualized the treatment regimen. Behar, Inc. have developed a first generation, engineering prototype of a dedicated, hand-held computer that can provide smokers with a structured, self-help cessation program. The engineering prototype has been piloted with a number of smokers to determine its acceptability, smokers' compliance, and options for software design. The device, based on a systematic nicotine reduction model of treatment, defines reductions as a function of baseline smoking and adjusts for deviations from initially determined rates of reduction. Phase 1 funding will allow completion of a second generation field prototype computer; modification of previously developed support material; evaluation of a series of clinical trials; and assessment of the acceptability of the field prototype in focus groups for smokers. The accomplishment of these tasks would prepare us to conduct a large scale, well-controlled evaluation of the effectiveness of computer assisted cessation in a Phase 2 trial.